Regulation of Soluble Guanylyl Cyclase, the NO-Receptor

PROJECT SUMMARY This is an application for an administrative supplemental equipment under our parent grant GM067640-16. The equipment we are requesting is at the center of our experimental strategy. It includes a) a new AKTA FPLC to replace and upgrade our old, outdated dysfunctional FPLC necessary for the purification of the enzyme-linked- receptor GC1, and b) a new spectrophotometer to replace and upgrade an old and broken spectrophotometer, which is critical in assessing the activity (via absorbance measurement) of the enzyme GC1. Both equipment will be used in the 2 aims of the project of our parent grant summarized below: Nitric oxide (NO) and cellular redox signaling are linked pathways crucially involved in the physiology and pathophysiology of the cardiovascular system. The main receptor for NO is soluble guanylyl cyclase (GC1), a heme-containing heterodimer. Upon binding of NO to the heme, GC activity is stimulated several hundred-fold to produce cGMP. Despite the critical role of the NO-cGMP pathway in vascular homeostasis and pathophysiology, the mechanisms of regulation and activation of GC1 are still poorly understood. GC1 is one of the most sought-after targets for treatment of cardiovascular diseases, in particular to overcome NO resistance in vascular dysfunction (i.e., when exogenous NO cannot correct disrupted vascular reactivity). We discovered that GC1 interacts with thioredoxin 1 (Trx1) via a mixed disulfide exchange and this interaction appears to protect GC1 from desensitization to NO stimulation. Interestingly, the GC1-Trx1 complex was increased by inducing cellular thiol oxidation with Angiotensin II and S-nitrosocysteine treatments. Our most recent investigations reveal the presence of disulfide bonds in GC1 and indicate that these disulfide bonds are different between unstimulated (basal) and NO-stimulated conditions, suggesting that thiol/disulfide switches could be involved in the mechanism of activation of GC1. We propose that the transition of GC1 from basal levels of catalysis to high rates of cGMP production in response to NO-heme binding is mediated by breaking of specific disulfide bonds and potential formation of different disulfides to create and stabilize a highly active catalytic conformation. Moreover, we will explore the hypothesis that the interaction between Trx1 and GC1 is involved in the mechanism of activation/deactivation by facilitating the reduction of disulfide(s). Using a combination of cellular, biochemical, Molecular Dynamics simulation and Mass Spectrometry experiments, we will identify and determine the function of disulfide bonds in Aim1 and establish the mechanism and biological relevance of GC1 interaction with Trx1 in Aim2. The unifying idea behind this project is the concept that NO signaling in cardiovascular biology via the classical NO-cGMP pathway is dependent on reactive disulfide(s) of GC1, their redox modulation and their redox- dependent interaction with other proteins. The etiology of cardiovascular function and misfunction could very well depend on the ability to maintain proper balance of GC1 thiol/disulfide switches.

Public health relevance
NARRATIVE Nitric oxide (NO), an endogenous gas, induces in blood vessels the production of a small molecule, cGMP, which vasodilates the vasculature. Dysfunction in the NO-cGMP pathway is responsible for many cardiovascular diseases including hypertension, erectile dysfunction and atherosclerosis. We seek to understand how this dysfunction takes place under oxidative stress.